MYCN drives a druggable SUMOylation program in neuroblastoma

Project Summary: High-risk neuroblastoma (NB) is responsible for ~15% of pediatric cancer-related deaths,
with nearly half of these characterized by MYCN amplification. The addition of anti-GD2 antibodies and
retinoids to maintenance therapy has improved the outcomes of these patients, but still more than 50% perish.
Omics studies in NB tumors has revealed that most NBs are driven by an adrenergic (ADRN) core regulatory
complex (CRC) of transcription factors that can be driven by MYCN and includes GATA-3, TBX2, HAND2,
PHOX2B, ISL1 and ASCL1. Genomically targeting the CRCs has been demonstrated to be highly effective,
however a pharmaceutical way to target the CRCs and in particular one that would be tolerated by the patient
has not been developed. Here we demonstrate a remarkable therapeutic vulnerability of MYCN-amplified NB
to SUMOylation inhibition. We provide evidence that toxicity involves disruption of the ADRN CRC which
requires the presence of MYCN. This pathway has become actionable, with the advent of the SUMOylation
inhibitor, TAK-981 (Subasumstat) now in multiple clinical trials. Thus, we propose we have uncovered an
ADRN CRC inhibition strategy that is effective in MYCN-amplified NB, suggesting a real therapeutic window.
Specific Aims
Specific Aim 1: Test a diverse set of well-annotated high-risk patient-derived xenograft (PDX) models for
efficacy and safety of SUMOylation inhibition in neuroblastoma alone and combined with maintenance therapy
Specific Aim 2: Investigate the mechanism of adrenergic (ADRN) core regulatory complex (CRC) disruption
following SUMOylation targeting
Study Design: We will further characterize the high sensitivity of TAK-981 in high-risk MYCN-amplified NB
patient-derived xenograft (PDX) models either alone or in combination with the anti-GD2 therapy, dinutuximab.
Through a series of genomic and proteomic studies, we will further categorize the mechanism of sensitivity to
SUMOylation inhibition. As TAK-981 induces NK cell activation, it is a rational inducing partner with the anti-
GD2 immunotherapy, dinutuximab. We will also investigate this combination in NB mouse models. In all, we
will attempt to gather the preclinical evidence that TAK-981 should be clinically evaluated in MYCN-amplified
NB patients.

Public health relevance
Project Narrative Despite being rare, MYCN-amplified neuroblastoma (NB) accounts for ~7% of all pediatric cancer related deaths and is driven by the oncogenic transcription factor MYCN and a MYCN-directed adrenergic (ADRN) core regulatory complex (CRC) of self-regulating and inter-regulated transcription factors that drive the MYCN- amplified NB transcriptome. In this proposal, we demonstrate MYCN drives a SUMOylation program in NB and MYCN confers synthetic lethality to the in-clinic SUMOylation inhibitor, TAK-981. TAK-981 disrupts the ADRN CRC, only in the presence of MYCN, to induce ADRN CRC collapse and cell death, and thus represents an exciting new therapy for this recalcitrant pediatric tumor.